Genetics, Cellular and Molecular Sciences Training Grant

DESCRIPTION (provided by applicant): The goal of the proposed research is to offer predoctoral training in the area of genetics, genomics, development, cellular biology, molecular biology, and/or biochemistry. Forty training faculty will participate in this program. The wide range of interests and expertise of the training faculty allows students to select among research programs that include molecular evolution, molecular biology, molecular genetics, developmental genetics, evolution of development, cell biology, microbiology, virology, structural biology, and biochemistry. A number of faculty have been hired in the past few years and add both breadth and depth in these areas. This interdisciplinary nature of our training program represents one of the major strengths of the program. The core curriculum is designed to give first year students a strong foundation in genetics, cell, developmental, and molecular biology, and biochemistry. Advance courses and other requirements are designed for the students to gain strength in their area of specialty, develop strong communication skills, and gain awareness of proper research conduct. Students are engaged in research training from the first year and are encourage to apply techniques and approaches derived from all of our areas of research strength. The majority of students supported by the training grant will be drawn from the Molecular Biology and Genetics (MBG) Program which awards Ph.D. degrees in Genetics, Molecular, Cellular and Developmental Biology, Microbiology, or Plant Sciences. It is also possible for students in other Departments or Programs to be supported by the training grant if their thesis mentor is a member of the Training Grant Faculty and the student fulfills the academic and thesis requirements that are related to the training mission of this program. We have had a long-standing tradition in the training of predoctoral students who have been productive, and established successful careers in biomedical related research. The training faculty remains dedicated to this mission. We are requesting continued funding of the current 16 training grant positions so that we can continue in this tradition.